Molecular Biology Of Mast Cell Growth And Differentiation

Human mast cells originate from pluripotential progenitor cells and migrate as immature cells from the bone marrow to tissue sites including the lung and gastrointestinal tract. There these precursors mature and participate in both innate and acquired immune responses with production of cytokines and other inflammatory mediators. Mast cell growth and development thus may occur in a tissue that interfaces with the external environment, potentially exposing mast cells during their development to bacterial products which could have an impact on their subsequent behavior. Consistent with this idea is the observation that mast cells are known to express Toll-like receptors (TLR) 1-7, and 9 both in vitro and in vivo; and exposure to such bacterial products as endotoxin or peptidoglycan leads to expression and release of cytokines. However, and in a related question, we explored whether bacteria-derived products alter the growth and development of HuMC.[unreadable] [unreadable] We thus performed long and short-term cultures to which we added LPS or PGN. We followed specific mast cell characteristics including growth; surface FcepsilonRI and CD117 expression; degranulation, LTC4 and PGD2 release; protease expression and composition, and cytokine release. [unreadable] [unreadable] Over 6 wks of culture, LPS had minimal effect on HuMC numbers but increased CD117, tryptase and chymase expression. PGN inhibited HuMC development. For mature mast cells, LPS in the presence of rhSCF (10 ng/ml) increased CD117, tryptase, chymase and carboxypeptidase expression, primarily in CD117low HuMC. LPS decreased FcepsilonRI expression and granule release; but had no effect on LTC4 and PGD2 production. PGN reduced HuMC numbers; and CD117 and tryptase expression. IL-1 and IL-6 (in addition to IL-8 and IL-12) were detected in short-term culture supernatants of LPS treated cells, and reproduced the increases in CD117, tryptase, chymase, and carboxypeptidase expression observed in the presence of LPS. Comparative studies with mouse bone marrow-derived mast cells from wild type, but not TLR4 knockout mice, showed increases in mRNA of mouse mast cell chymases MMCP-1, MMCP-2 and MMCP-4.[unreadable] [unreadable] We thus concluded PGN inhibits human mst cell growth, while LPS exerts its primary effects on mature mast cells by altering cytokine production and protease composition, particularly at low concentrations of SCF. These data thus demonstrate the ability of bacterial products to alter human mast cell mediator production, granular content, and number which may be particularly relevant at mucosal sites where mast cells are exposed to these products.[unreadable] [unreadable] In a question relevant to the evaluation of allergic sensitization, we are examining the ability of a component of shrimp, a major food allergen, to directly activate human mast cells. It is known that shrimp extracts, used as skin testing reagents, cannot be used at higher concentrations, as this leads to non-specific reactions; that is, these reactions occur in all individuals and thus do not correlate with clinical sensitivity. To identify the component of shrimp that directly activates mast cells, we fractionated shrimp extracts by size using column chromatography (S-300) and screened fractions for direct mast cell degranulating activity using the LAD2 human mast cell line. Active fractions were sequenced. Tropomyosin (Pen a 1) was identified as the active material. Recombinant Pen a 1 (rPen a 1) was used in degranulation experiments and did directly degranulate mast cells.[unreadable] [unreadable] In vitro degranulation experiments were then undertaken. Pertussis toxin and inhibitors of PI3K, PLCgamma, PKC and Src did not prevent degranulation. rPen a 1 did increase cytosolic calcium concentrations by promoting liberation from intracellular stores and calcium entry. These observations appear to explain how shrimp extracts at higher concentrations lead to non-specific skin test reactivity. In vivo experiments in an animal model are underway.